Reducing Ethnic-racial Disparities in Cardiac Arrest Survival Outcomes (RED-CASO)

PROJECT SUMMARY / ABSTRACT
The public health burden of out-of-hospital cardiac arrest (OHCA) is enormous, affecting ~350,000 individuals
each year in the U.S. and is the third leading cause of death. To improve our understanding of OHCA, the
Cardiac Arrest Registry to Enhance Survival (CARES) was launched by Emory University and the Centers for
Disease Control and Prevention. Through >70 peer-reviewed publications over the past 2 decades, CARES
has transformed our understanding of the epidemiology and outcomes of patients with OHCA. Yet, little is
known as to how some emergency medical service (EMS) agencies achieve higher survival rates for their
patients with OHCA than other agencies. While variation in OHCA survival is largely believed to be due to
adoption of key care processes by EMS agencies in the prehospital setting, how these processes are
employed in routine practice, the underlying factors contributing to their successful implementation, and
effective interactions between EMS agencies with the community, first responders (e.g., police, fire), 911
dispatchers, and hospitals have not been systematically defined. Moreover, despite the fact that Black and
Hispanic patients have lower survival rates for OHCA than White patients, there is scant research on how to
reduce disparities in OHCA survival and how top-performing EMS agencies that work in majority Black or
Hispanic communities overcome additional barriers to prehospital OHCA response and care.
Accordingly, we propose the RED-CASO (Reducing Ethnic-racial Disparities in Cardiac Arrest Survival
Outcomes) study to address these critical gaps in knowledge and to lay the foundation for quality improvement
efforts to reduce disparities in OHCA survival. First, we will identify top-performing and bottom-performing EMS
agencies in OHCA survival, with a focus on those that work in majority Black or Hispanic communities.
Second, we will identify ‘best practices’ at top-performing EMS agencies in OHCA survival through detailed
interviews with key stakeholders during site visits. We will intentionally sample EMS agencies which work in
majority Black or Hispanic communities, and these agencies will comprise at least half of the sites visited. And
third, we will validate these best practices associated with EMS agencies with the highest survival rates for
OHCA. We will use a sequential mixed-methods approach with a focus on identifying best practices at top-
performing EMS agencies which work in communities where most residents are Black or Hispanic. We will
build on work by our investigative team to systematically understand factors associated with survival for other
emergency settings (in-hospital cardiac arrest) and leverage our team’s multidisciplinary expertise in
cardiology, emergency medicine, epidemiology, and mixed methods research. Findings from this study will be
used to construct a ‘best practices guide’ for OHCA that can be implemented by EMS agencies both within
CARES and with national partners such as the American Heart Association to improve OHCA survival in
predominantly non-White communities and, in turn, reduce racial and ethnic disparities in OHCA outcomes.

Public health relevance
PROJECT NARRATIVE Out-of-hospital cardiac arrest (OHCA) is a leading cause of death in the U.S., affecting 350,000 individuals annually, and is associated with high mortality and morbidity. The proposed RED- CASO (Reducing Ethnic-racial Disparities in Cardiac Arrest Survival Outcomes) study will identify best resuscitation practices at EMS agencies with the highest survival rates for OHCA, especially at EMS agencies that work in majority Black or Hispanic communities. This research is relevant to the mission of the National Heart Lung and Blood Institute because it will identify best practices, improve outcomes, and has the potential to reduce racial and ethnic disparities in survival for a condition with high public health burden .